Understanding Diabetes Heterogeneity via Mining Multimodality Interconnected Data

Understanding Diabetes Heterogeneity via Mining Multimodality Interconnected Data
Abstract. Diabetes is a prevalent and highly heterogeneous disease that incurs tremendous human, economic, and so-
cial costs globally. Prediabetes and early-stage type 2 diabetes often do not have single strong indicates or symptoms,
posing great challenges for early detection and intervention. Moreover, once into a later-stage, diabetic patients are at
high risk of developing various health problems such as heart disease, vision loss and kidney disease, which further com-
plicates effective healthcare and may eventually lead to consequences from blindness to amputations to limited social
interactions due to mobility. Unfortunately, current subtyping of diabetes has failed to decouple such heterogeneity.
Recent remarkable advances in biotechnology have led to a signiﬁcant production of high throughput patient data such
as electronic health records (EHRs), multi-omics, and structured surveys, providing tremendous promises to powerful
quantitative approaches towards the understanding of diabetes heterogeneity. However, existing machine learning (ML)
models ignore the higher-order interconnections among various disease variables, thus failing to differentiate complex
ﬁne-grained subtypes and extract subtle corresponding phenotypes– regarding speciﬁc combinations of disease vari-
ables. Moreover, most existing studies focus on single sources of data such as clinical, molecular or behavioral, failing to
discover integrative biomarkers towards even more effective disease detection, analysis and treatment. Often case, these
methods also rely heavily on dataset-speciﬁc feature preprocessing and fail to transfer from one cohort to another.
As a computer scientist aiming at bridging data science and diabetes management, I have developed a well-structured
training pan in this proposed K25 project, and my primary goal is to develop a high-impact and practical ML system that
can be used to perform precise detection, in-depth analysis and cost-effective treatment of diabetes. To fully decouple
the heterogeneity of diabetes from complex patient data, I propose (1) a hyper-hetero-graph data structure (H2G) to
facilitate the comprehensive representation of patients and deep identiﬁcation of diabetic characteristics regarding the
interconnections among various disease variables and (2) a specialized graph neural network model (H2GNN) capable
of modeling H2G along with a temporal component to capture the full trajectories of disease progression and a self-
clustering component to identify novel subtypes of diabetes. Leveraging the national All of Us dataset from NIH with
EHRs, genomics and surveys of 329K+ patients (42K+ diabetic), I propose to (1) apply the model to clinical data (EHRs)
towards precise early diabetes detection, (2) incorporate molecular data (genomics) towards in-depth diabetes patho-
logical analysis, and (3) further incorporate behavioral data (surveys) towards personalized diabetes treatment design.
Finally, we will iteratively evaluate our system and its discovered subtypes based on both All of Us and our independent
local dataset NELL curated from Emory Healthcare System with multimodality data of 295K patients (39K diabetic).
This project is consistent with NIDDK's commitment to translational research on chronic diseases, and aligns well with
ADA's recent initiative towards diabetes precision medicine. Results of this project will also inform the development of
powerful quantitative approaches for a broader spectrum of diseases.

Public health relevance
Project Narrative Diabetes is known to be highly heterogeneous with various phenotypes, causes and outcomes. Current effective subtyp- ing of diabetes is limited due to the inability of modeling complex disease variables potentially interconnected across multiple modalities of patient data. This project develops a novel and practical analytic tool to understand the hetero- geneity of diabetes to enhance its precise detection, in-depth analysis and personalized treatment.